Technology Research in Chronic & Critical Illness

The use of technology to monitor health, deliver care, and manage chronic and acute conditions is rapidly expanding. It is often described as a driving force in reshaping health care delivery. Given the fast pace of technological advancement and the growing number of older adults and individuals managing complex health needs in community settings, nurse scientists must be equipped to evaluate how technology and clinical data science can support improved patient outcomes in collaboration with interdisciplinary teams. The overarching goal of this training program remains to provide rigorous research training and interdisciplinary contextualization to build nursing science aimed at improving health, managing illness, addressing health challenges, and enhancing quality of life through the aid of technology and clinical data science. We continue to place strong emphasis on leveraging technology and clinical data analytics in healthcare settings. Based on the growing need for nurse researchers to lead interdisciplinary teams and contribute their unique domain expertise to these rapidly growing fields, the specific aims are to provide trainees with: 1. the theoretical and conceptual foundations to support the development of a program of research that examines ways that technological solutions can be used to address unmet clinical needs by enabling the prevention, detection, prediction, or management of health-related problems, 2. the methodological skills to combine nursing domain knowledge and emerging clinical data science strategies to better understand complex health phenomena 3. the knowledge and skills to design technology and clinical data science studies to improve health outcomes and quality of care 4. the skills to lead interdisciplinary teams to conduct research of impact that propels technology solutions and clinical data science along pathways of translation into practice or commercialization. Funding is requested to continue the program for five years, supporting three predoctoral and two postdoctoral trainees annually. It is essential that nurse researchers are equipped to evaluate both the effectiveness and the practical implementation of advanced health technologies, including their use by patients and providers. Additionally, the ability to collaborate across disciplines is critical for success in this field. This program will prepare trainees to lead cutting-edge research in an area of increasing importance to health care delivery.

Public health relevance
The use of technology to deliver health care and manage chronic and critical illness is becoming increasingly widespread. The overarching goal of this T32 program, Technology Research in Chronic and Critical Illness, is to provide rigorous research training and interdisciplinary professional development to advance nursing science focused on promoting health, managing illness, and improving quality of life through the application of technology and clinical data science. This program will prepare nurse trainees to lead innovative, high-impact research in this rapidly evolving area.